Pilot Projects Core

The Pilot Projects Core will support new research initiatives during the formative stage by providing seed funding to small, short-term (1-2 year) pilot research projects selected through competitive review. Applications will be solicited from the general UMMS scientific community and their collaborators and will be reviewed by a panel of senior UMMS faculty investigators from the Program in Immunology and Virology. The goals of the Core will be to facilitate the entry of new investigators into the biodefense research field and improve the competitiveness of projects for external funding. Success of the program will be evaluated through review of the record of publications and success at securing external funding. The Pilot Projects program is expected to foster innovation and career development, aiding the overall objectives of the CTRHIB and the NIAID biodefense research program.

Public health relevance
The Pilot Projects Core helps the overall Center to foster innovation and career development by supporting small, short-term (1-2 year) pilot research projects in the early stages of development. The efforts of the Core are expected to help new investigators enter biodefense research and obtain independent external funding.